Structural Pharmacology of GIRK Channel Disease Mutants

Summary
Several human diseases are caused by mutations in potassium channels (channelopathies) that are either loss-
or gain-of-function. Missense mutations in KCNJ6 (GIRK2) have been linked to Keppen-Lubinsky Syndrome
(KLS), a disorder characterized by lipodystrophy, severe developmental delay, intellectual disability, hypertonia,
hyperreflexia and growth retardation. GIRK2 is a member of the GIRK channel family, which includes inwardly
rectifying potassium (Kir) channels that are activated by G proteins. Activation of GIRK channels hyperpolarize
neurons leading to reduced neuronal activity. Mutations in human GIRK2 (T152, G154S/C, L171R) have been
identified in KLS, with each mutation leading to a loss of K+ selectivity and aberrant constitutive activation.
However, the structural mechanisms underlying the change in ion selectivity and gating with KLS mutations in
GIRK2 are poorly understood. These changes in channel properties convert GIRK2 from inhibitory to strongly
excitatory (gain-of-function), contributing to the severe neuropathology and neurological changes observed in
KLS patients. Currently, there are no treatments that target these channels, and current FDA approved drugs
are inadequate for treating for KLS patients. We propose to elucidate the molecular mechanisms underlying the
loss of K+ selectivity and G protein-independent activity with GIRK2 KLS mutations. We will then identify and
characterize novel inhibitors specific for GIRK2 KLS channels using virtual docking and functional assays. In
addition, little is known about the functional consequence of GIRK2 KLS channels expressed in human neurons.
We will develop a human cell-based model of KLS using hiPSC-derived neurons that co-express GIRK2 KLS
channels. Using these KLS neurons, we will evaluate the potential therapeutic effect of GIRK2 channel inhibitors
on neuronal function. To carry out these aims, our team implements a multi-disciplinary approach, combining
high-resolution channel structures (CryoEM), computational docking, drug development, and human neurons.
Identification of a selective inhibitor of the KLS channels could provide the foundation for developing a novel
treatment. If substantiated, our approach of identifying novel channel inhibitors would be transformative in
treating neurological disorders caused by mutant potassium channels as well as other ion channels.

Public health relevance
G-protein activated potassium channels are important for controlling neuronal activity. Using structural, pharmacological, and functional approaches, we will identify compounds that modulate a subset of human G-protein activated potassium channels containing disease mutations.